Rickettsiales: Host-Vector-Pathogen Interactions

Workshop Summary: Rickettsial Diseases: Host-­Vector-­Pathogen Interactions Rickettsial diseases are significant causes of morbidity and mortality. They are responsible for the majority of hospital admissions, intensive care admissions, and fatalities among all tick-­borne infections. Many are emerging or re-­emerging, have biothreat implications, and/or are neglected. Rickettsial diseases have been responsible for the loss of millions of lives and were second only to malaria as the cause of febrile illness among troops in World War II, the Korean War, and the Vietnam Conflict. No vaccine for any rickettsial disease exists, and the interactions of these bacteria with their arthropod vectors and mammalian hosts are poorly defined. Filling such knowledge gaps will improve understanding of rickettsial pathobiology and promote development of novel treatments. Indeed, the 2011 Institute of Medicine of the National Academies workshop report, “Critical needs and gaps in understanding, prevention, amelioration, and resolution of Lyme and other tick-­borne diseases? emphasized that understanding these pathogens’ factors that enable them to survive and cause disease would lead to development of novel countermeasures. The complexity of the challenge of preventing rickettsial diseases is due, at least in part, to the evolutionary relationships between the etiologic agents, their arthropod vectors, and mammalian hosts. The American Society for Rickettsiology (ASR) has a long history of providing forums that foster scientific interactions and rich intellectual exchange among world-­renowned experts on rickettsial diseases. The 28th Meeting of the ASR will be held June 11-­14, 2016 in Big Sky, Montana. Approximately 200 attendees representing junior and established scientists from academia, government, and industry are anticipated. The conference’s overarching goal is to advance knowledge and stimulate interactions among these researchers through lectures, short oral presentations, poster sessions, and networking opportunities. To address the aforementioned knowledge gap, we propose a small workshop within the framework of the 28th meeting entitled, “Rickettsial Diseases: Host-­Vector-­Pathogen Interactions.” The workshop’s aims are to (i) provide a forum that promotes scientific exchange among participants and experts through invited keynote and plenary lectures, short talks, and posters by leaders and junior investigators that study rickettsial and other vector-­borne diseases;? (ii) offer a program that presents the latest, cutting-­edge research of rickettsial and other diseases caused by arthropod-­borne/obligate intracellular pathogens;? (iii) provide a venue that fosters intellectual exchange and networking opportunities between junior and senior investigators;? and (iv) promote participation by those that are early in their careers and that are underrepresented in the biomedical sciences, including women. Efforts will also be made to accommodate attendees in need of child care. Support for the workshop is requested to cover the cost of coordination, facilities, travel expenses for invited speakers and selected attendees, and for audio-­visual services and program production.

Public health relevance
Rickettsial diseases caused by arthropod vector-borne obligate intracellular bacteria have impacted human health throughout history, and these infections continue to emerge or reemerge today. As a means of addressing a fundamental knowledge gap recognized in a recent report by the Institute of Medicine of the National Academies, the workshop will bring together researchers whose interests center on rickettsiae-vector and rickettsiae-host interactions to foster intellectual exchange and catalyze collaborative research efforts to fill these knowledge gaps and translate research into improved means for preventing, treating, and diagnosing rickettsial diseases. Over 20 committee members representing a mix of senior and junior scientists from diverse and underrepresented groups are on board to participate, and strategic efforts are in place to ensure that attendees that are from underrepresented groups, have disabilities, and have small children are fully engaged in the workshop.